Exploring genomic and cellular determinants of gene therapy durability

PROJECT SUMMARY
Since the identification of disease-causing genes, the promise of gene correction seemed out of reach for
decades. New delivery vehicles and gene-editing tools have brought the field to an inflection point in our ability
to address the molecular basis of disease. Remarkable results in spinal muscular atrophy, inherited blindness,
and hemoglobinopathies are just the beginning of a revolution in precision medicine. However, many unknowns
remain including the durability of gene replacement therapy, the adaptive immune response to gene therapies,
and unintentional genomic changes including vector integrations. In the clinic, these concerns are reminiscent
of gene therapy failures of the past, and recent clinical trial deaths in high-dose adeno-associated virus (AAV)
clinical trials illustrate the significance of improving our understanding of the host response to gene therapy. We
have previously shown that, in the absence of an immune response, CRISPR-mediated genome editing effects
are maintained for the lifetime of an animal. However, the adaptive immune response can reverse gene
correction. Additionally, we observed a high level of vector integration leading to chimeric transcripts. The
biological consequences of these genomic and transcriptomic alterations are unknown. The goal of this MIRA
research program is to develop a better understanding of genomic, epigenomic, and transcriptomic outcomes of
gene therapy. We aim to answer long-standing questions including: (1) What are the epigenetic and
transcriptional consequences of vector integration on long-term outcomes? (2) Is there a cell, tissue, or promoter
dependency on the behavior of the vector genome? (3) Is there a differential host response to integrated vectors,
episomal vectors, or alternate delivery vehicles? To answer these questions, we will use a convergence of tools
and techniques including CRISPR-mediated targeted integration, PCR-free long-read DNA sequencing, and
spatial biology. These approaches are supported by robust preliminary data in the PI’s lab. Using nanopore long-
read sequencing, we have developed methods for characterizing full-length AAV insertions and epigenetic
alterations to AAV genomes and resulting transcriptional changes. We are adapting spatial biology techniques
to characterize host responses to divergent gene therapy vehicles in skeletal muscle, cardiac tissue, liver, and
others. Answers to these questions will enable improved design of gene therapy approaches with the aim of life-
long correction in a range of diseases.

Public health relevance
PROJECT NARRATIVE While gene therapy has made major strides in the treatment of a broad range of diseases, many mechanisms that control long-term expression and phenotypic improvements remain unknown. This work aims to build an in- depth analysis of the genetic and cellular determinants of gene therapy longevity which is consistent with the goals of NIGMS.